Peptide Mimics of the Collagen Triple Helix

Project Summary/Abstract
Protein-protein interactions (PPIs) are involved in a diverse array of critical biological processes,
including cell proliferation, growth, differentiation, and apoptosis. To date, there is no general way to
modulate collagen protein-protein interactions, and many fundamental aspects of biomolecular
recognition are still unknown. Specifically, numerous interactions between collagen triple helices and
proteins are not fully characterized or understood. We have recently shown that collagen aza-peptides
in which at least one alpha-carbon atom has been substituted with nitrogen, have additional interstrand
hydrogen bonds in their collagen triple helix, resulting in hyperstability and more efficient self-assembly.
As a result, even short collagen aza-peptides reliably self-assemble into thermostable triple helices,
making them a promising choice for novel triple helix mimics. With this project, we propose to use
minimal aza-peptides to create linear and cyclic collagen peptide triple helix mimics. Our specific aims
are as follows: 1) Synthesize and characterize hyperstable synthetic mimics of collagen peptides; 2)
Synthesize and characterize cyclic collagen peptide triple helix mimics (CCP-mimics); 3) Characterize
protein interactions our synthetic collagen peptides. Aza-peptides will be synthesized using solid-phase
peptide synthesis (SPPS) in order to introduce aza-amino acids into the collagen backbone at precise
locations and optimize thermodynamic stability of the linear and cyclic peptides. The modular nature of
our new collagen peptide systems will provide highly tunable platforms into which any biologically
relevant protein binding sequence can be integrated. Our collagen peptide mimics will serve as new
chemical tools for understanding the fundamental biology and biochemistry of the collagen-protein
interactome. The proposed studies could ultimately serve as the fundamental science leading to future
biomedical treatments for pathologies in which precisely modulating collagen-protein interactions could
significantly enhance patient outcome.

Public health relevance
Project Narrative: Public Health Relevance Protein-protein interactions (PPIs) are involved in nearly all biological processes, including cell proliferation, growth, differentiation, and apoptosis. Identification of collagen-protein interaction modulators will aid in the development of novel therapeutics for maladies including cancer, fibrosis, diabetes, and neurodegenerative disease in addition to serving as important chemical tools for elucidating fundamental aspects of human biology and biochemistry. Hyperstable collagen peptides and peptide mimics containing aza-amino acid residues offer the possibility to study previously elusive interactions between collagen triple helices and the myriad proteins that comprise the human collagen interactome.